Survey, Recruitment, and Biospecimen Collection Shared Resource

SURVEY, RECRUITMENT & BIOSPECIMEN COLLECTION SHARED RESOURCE: PROJECT SUMMARY
The Georgetown Lombardi Comprehensive Cancer Center (LCCC) Survey, Recruitment & Biospecimen
Collection Shared Resource (SRBSR) was established in July 2011 and has been CCSG supported since May
2014. The SRBSR is co-led by an oncology clinical research nurse administrator, Colleen McGuire RN, MSN,
and a health services researcher, Arnold Potosky, PhD, MHS. The SRBSR provides LCCC Members with a
comprehensive suite of services designed to meet their research needs, from consultative services prior to study
initiation through survey development and implementation, database programming and preparation, subject
recruitment and tracking, biospecimen acquisition, and data entry and data management. The SRBSR maintains
and continuously updates a centralized, unified, and efficient patient registry (Georgetown MedStar Research
Registry [GMR2]) and the Familial Cancer Registry (FCR) to facilitate subject recruitment and biospecimen
acquisition for LCCC patients. Most (97%) subjects currently enrolled in this patient registry have consented to
have their samples retained for future studies and to be contacted about future studies for which they may be
eligible (96%). The SRBSR serves the needs of investigators from various disciplines, including behavioral
scientists, clinical and translational researchers, epidemiologists, and basic scientists. The SRBSR receives
input from the SRBSR Advisory Committee (AC) annually. In response to the prior critique to obtain more user
feedback and to facilitate navigation of the SR, the SRBSR implemented three additional user surveys to
prioritize development and assess programmatic needs, redesigned the SR webpage, and created an online
request form to enhance navigation by prospective users. With respect to use, the SRBSR has enrolled 3,806
subjects into 19 studies in the current project period, including 5 clinical trials. During this time, the SRBSR
collected 844 liquid and 64 tissue biospecimens. To ensure synergy with other Shared Resources, the SRBSR
works closely with the Histopathology & Tissue Shared Resource and the Tissue Culture & Biobanking Shared
Resource, which process and store the biospecimens. The SRBSR assists investigators in designing and
implementing surveys based on robust and reliable data collection platforms. The SRBSR also validates, tracks
and cleans datasets for analysis. The SRBSR has provided support for all three LCCC Research Programs. In
FY2022, the SRBSR provided services to 24 LCCC Members across all three Research Programs (3 Cancer
Cell Biology Members, 4 Cancer Host Interactions Members, and 17 Cancer Prevention and Control Members).
In the recent project period, the impact of the SRBSR is demonstrated through the enabled success of 34 peer-
reviewed publications, 5 clinical trials, and 39 extramurally funded research project grants for LCCC Members
using SRBSR.